Admin Core

PROJECT SUMMARY
This Administra7ve Core (Core A) supports the NIH ICEMR “Mul7disciplinary research for malaria
control in West Africa” which is designed to inves7gate the epidemiology, immunology and
pathogenesis, and transmission of malaria in West Africa. This ICEMR is led by a PI/PD from Mali.
Thus, this Administra7ve Core will be based in Mali, at the University of Bamako. The purpose of
the Administra7ve Core is to ensure the eﬀec7ve overall administra7on, coordina7on, and
management of the Center. There are four speciﬁc aims: 1) Track scien7ﬁc progress and
accomplishments for each of the individual Projects and Cores; 2) Ensure the coordina7on of
related studies at diﬀerent ﬁeld sites and laboratories; 3) Ensure compliance with IRBs and other
regulatory authori7es for studies of human subjects; 4) Develop administra7ve guidelines,
including subcontracts, to deﬁne the responsibili7es of inves7gators, and to ensure the
responsible management of funds provided for these studies. The long-term objec7ves are to: 1)
Provide administra7ve and scien7ﬁc management support for each of the individual ICEMR
Projects and Cores; 2) Strengthen exper7se in research administra7on for the ICEMR at University
of Bamako in Mali; 3) Provide Post-Doctoral research support and opportuni7es to several young
returning trainees in Mali; 4) Network with other ICEMRs and the interna7onal community to
promote malaria research training and capacity building in Mali and other countries in West
Africa. The administra7ve and scien7ﬁc management of this Core will promote interdisciplinary
synergism among ICEMR team members and a growing network of interna7onal collaborators to
facilitate “cu]ng edge science” needed meet the overall basic science and public health goals of
this ICEMR.